The interface between glucocorticoid signaling and histone acetylation in erythropoiesis

PROJECT SUMMARY/ABSTRACT
Chronic glucocorticoid therapy is a mainstay of treatment for Diamond-Blackfan anemia (DBA), but leads to a
number of toxicities including, but not limited to, gastric ulcers, immunosuppression, hyperglycemia, renal
dysfunction, steatosis, adrenal suppression, hypertension, osteoporosis, and cataracts. These toxicities are
severe enough that nearly half of DBA patients must discontinue glucocorticoid therapy. Alternatives to
glucocorticoids include chronic red cell transfusions and hematopoietic stem cell transplantation, but chronic
transfusions are associated with a number of toxicities from iron overload and alloimmunization, and stem cell
transplantation carries risks of mortality from conditioning toxicity and graft versus host disease. Thus, new
approaches for reducing toxicity when treating DBA are required. Over the course of our prior research funded
by the K08 awarded to the principal investigator, we identified inhibition of histone acetyltransferase (HAT)
activity as an intervention that increases the number of erythroblasts produced by an individual early erythroid
progenitor cell. Furthermore, HAT inhibition also synergized with glucocorticoids to increase erythroblast
production by over an order of magnitude. The goal of this proposal will be to advance a new research focus
assessing the interplay between glucocorticoid signaling and HAT regulation of erythropoiesis. The genesis of
this line of investigation arose from follow-up experiments to the principal investigator’s K08, but have diverged
from the K08 aims of identifying specific gene targets of glucocorticoid receptor and instead focus on
glucocorticoid interactions with epigenetic regulators. We will (i) determine if glucocorticoid receptor directly
interacts or colocalizes with HATs, and (ii) determine if HAT inhibition phenocopies glucocorticoid-induced
slowing of erythroid differentiation as a mechanism for increasing erythroid progenitor cell proliferative capacity.
Through these efforts, we will generate data that informs strategies for preclinical development of HAT
inhibition for DBA, and expand the repertoire of the principal investigator’s research program.

Public health relevance
PROJECT NARRATIVE Diamond-Blackfan anemia (DBA) patients urgently need new treatment modalities that allow them to decrease the amount of glucocorticoid steroids they use to maintain adequate red blood cell counts. We have recently found that drugs affecting the acetylation of histones may cooperate with glucocorticoid steroids to markedly enhance red cell production. This proposal will provide critical data on the mechanism by which this cooperativity occurs, which will be necessary for the rational development of this class of drugs as a potential novel treatment for DBA.